GluN2D in Development and Disease

PROJECT SUMMARY/ABSTRACT
NMDA receptors (NMDARs) are ligand-gated ion channels that are activated by glutamate, the
principle excitatory neurotransmitter of the brain. Missense mutations in NMDAR subunits are
associated with multiple neurodevelopmental disorders including autism, epilepsy and
morphological anomalies. Nevertheless, it is unclear how particular functional alterations
produce disease, especially as both gain and loss of function alleles have been identified with
the same disorders. This proposal uses zebrafish as a model to explore the developmental roles
of the understudied GluN2D subunit, which is associated with a severe neurological disorder,
Developmental and Epileptic Encephalopathy (DEE). Based on novel preliminary data that
shows NMDARs repress forebrain neurogenesis, we hypothesize that GluN2D dysfunction
alters early neurogenesis and the subsequent balance of excitatory and inhibitory neurons. We
propose two aims to test this premise. In Aim 1 we will determine the effects of complete loss of
GluN2D on neurogenesis to establish a foundation for understanding the pathogenic impacts of
GluN2D disease variants. In Aim 2 we will generate zebrafish models harboring DEE-associated
GluN2D variants to directly assess their effects on neurogenesis. This work will provide new
insights into the role of GluN2D in early development and establish a scalable strategy to
interrogate the pathogenic mechanisms produced disease associated NMDAR variants that
result in autism, epilepsy, and other neurodevelopmental disorders.

Public health relevance
PROJECT NARRATIVE Developmental and Epileptic Encephalopathy (DEE) is a severe condition associated with mutations in the GluN2D NMDAR subunit. Children are typically affected in the first months of life. There is no effective treatment and the exact developmental mechanism that produces the disorder known. We seek to address how dysfunction in GluN2D, alters early neural development and leads to clinical phenotypes.